Administrative Core

ADMINISTRATIVE CORE PROJECT SUMMARY The Administrative Core of the P30 Center for Technology and Behavioral Health (CTBH), under the leadership of the Center Director’s Office, will facilitate and support the activities of all five Cores of CTBH, so that all Cores collectively achieve the Overall Aim of the Center. Specifically, the Administrative Core will enable the integration of expertise across multiple disciplines and provide an infrastructure to enhance the quality, pace of achievement, and impact of innovative scientific research that combines science-based behavior change interventions with state-of-the-science technologies to create, evaluate, and disseminate digital therapeutics targeting substance use disorders (SUDs) and co-occurring conditions. In our 9 years of funding thus far, we grounded the Core’s organizational structure, management approach and communication infrastructure in empirically-based strategies to optimize communication, collaboration and productivity among geographically dispersed teams. We have found this model to be particularly well-suited to our Center, given the Center’s focus on transcending traditional models of intervention delivery to use state-of- the-science technologies to overcome time and space constraints to deliver behavior change interventions in a wide array of settings. Further, we have continually refined our approach based on lessons learned over 9 years of collaborations. In the renewal period, we plan to continue effective communication and collaboration with our Center partners using approaches grounded in the empirical literature and in light of our experiences to date. This Core will provide scientific and programmatic leadership to ensure efficient and successful coordination and integration of the activities across Center Cores. The overall programmatic structure and management approach has been designed to ensure scientific leadership and direction (under the oversight of the Director’s Office) that effectively promotes interdisciplinary scientific interactions, provides internal quality control of research activities, and facilitates collaborative publications, pilot projects, and generation of grant applications, while maximally utilizing the Center’s research capabilities. Additionally, this Core will provide an infrastructure to enhance synergy among an interdisciplinary expert team by facilitating productive communication, centralization of knowledge and resources, and integration of methods and results across individual research projects.